An Immersive Experience in Medical Genomics

Project Summary
Next generation sequencing (NGS) has transformed the field of genomics, bringing it to the forefront of
healthcare, however the rapid pace of technological developments in the field challenges even field experts to
stay current. The successful implementation of genomics into clinical practice requires much more than a
superficial understanding of the technology. The proposed course, "An Immersive Experience in Medical
Genomics" is designed for a broad audience of clinicians seeking a strong foundation in genomics, and will be
structured to facilitate collaboration and crosstalk across disciplines. It builds upon the currently funded
program developed at Children's Mercy Hospital (CMH) that uses a multimodal educational approach including
Personal Genome Education Testing (PGET) to engage participants in genomics and precision medicine. The
central goal of the proposed course is to facilitate the implementation of genomic medicine into all aspects of
clinical practice. We will accomplish this goal through the following specific aims: 1) create a flexible teaching
model to optimize genomic education through a combination of well-designed e-learning modules, lectures,
case-based discussions, and hands on workshops, 2) educate course participants on special ethical, legal, and
social implications (ELSI) of genomic testing, 3) to promote the integration of clinical genomic research into
traditional clinical practice. Short and long-term impacts for purposes of curriculum modification and impact will
be collected, with results distributed through scholarly activities (presentations and publications). The
proposed course will enable The Center for Pediatric Genomic Medicine (CPGM) to share our translational
genomic expertise with 250 clinicians, committed to the integration of genomic guided precision medicine into
clinical practice, over 5 years.

Public health relevance
Project Narrative Next generation sequencing (NGS) has transformed the field of genomics, bringing it to the forefront of healthcare, however the rapid pace of technological developments in the field challenges even field experts to remain current. The successful implementation of genomics into clinical practice requires much more than a superficial understanding of the technology. The proposed course, "An Immersive Experience in Medical Genomics" is designed for a broad audience of clinicians seeking a strong foundation in genomics, and will be structured to facilitate collaboration and crosstalk across disciplines.